Vaginal Tactile Imager for Pelvic Floor Biomechanical Assessment

DESCRIPTION (provided by applicant): Pelvic organ prolapse is a highly prevalent condition affecting at least 50% of women in the US during their lifetimes. Some loss of utero-vaginal support occurs in most adult women, however, the true etiology of prolapse and differences seen among individuals is not entirely understood. Changes in the elasticity of the vaginal walls, connective support tissues and muscles are thought to be significant factors in the development of pelvic organ prolapse. We propose to develop a device entitled Vaginal Tactile Imager (VTI) for 3-D visualization and assessment of mechanical properties of pelvic floor tissues. VTI is based on the Tactile Imaging (TI) technology founded on the principles similar to those of manual palpation. In Phases I and II we designed and built a and prototypes of VTI with tactile sensor array and a motion tracking sensor, completed VTI testing and verification with the tissue mimicking phantoms, completed Phase I and initiated Phase II clinical study. Clinical results demonstrated capability of the proposed approach for 3-D imaging of the vagina and pelvic floor support structures. Our findings suggest that the normality ranges for tissue elasticity of vagina and its support structures evaluated by VTI might be used as the markers in diagnosis of pelvic floor conditions. We further demonstrated VTI capability in characterization of outcome of pelvic floor reconstructive surgery. Tactile Imaging technology developed at Artann Laboratories is highly innovative and unique. Artann scientists are the first in the world to introduce and develop Tactile Imaging technology into the practical and proven successful applications described in numerous publications and 21 issued patents. The main goal of Phase IIB is to transform the Phase II VTI ¿-prototype into medical device ready for regulatory review and commercialization. Upon completion of regulatory compliance testing, verification and clinical validation of the VTI, technical and clinical files will be prepared for FDA application. The endpoint for the Phase IIB of the project is the FDA 510(k) submission. The VTI commercialization will follow the FDA approval. The completion of proposed project promises to gain scientific knowledge, provide new technical capability and improve clinical practice in gynecology.

Public health relevance
PUBLIC HEALTH RELEVANCE: Pelvic organ prolapse is a highly prevalent condition affecting at least 50% of women during their lifetimes; that impairs the quality of life and results in over 200,000 surgical procedures annually in the United States. The goal of this project is to develop Vaginal Tactile Imager (VTI) for real time 3-D elasticity imaging and quantitative characterization of pelvic floor tissues. Based on the clinical data VTI has the potential to predict women risk of developing pelvic prolapse, aid in staging and individually optimized treatment of the disease. __SpecificAimsTextDelimiter__ Specific Aims Overview Pelvic organ prolapse (POP) is a highly prevalent condition affecting approximately 50% of women in the U.S. during their lifetimes [1, 2]. POP carries an associated lifetime risk of surgery of 19% based on the most recent cross-sectional rates, a figure higher than the 11-12% previously reported for U.S. managed-care populations [3]. Despite the high number of women affected by and treated for these conditions, the true etiology of POP and variations seen among individuals are not entirely understood. Changes in the elasticity of the vaginal walls, connective support tissues and muscles are thought to be significant factors in the development of POP [4-7]. Characterization of the biomechanical properties of pelvic support tissues and the variations seen from patient to patient will allow for needed progress in the field by assessing: 1) how changes in tissue elasticity are related to the development of POP and 2) how functional tissue Transvaginal probe with tactile and motion tracking sensors Imaging Software • system operation • data acquisition • visualization • analysis Examination Report • 2-D/3-D images • tissue characterization Figure 1. In Phase I and II we have designed and tested the Vaginal Tactile Imager allowing 3-D tactile imaging of pelvic floor tissues and quantitative assessment of their mechanical properties. elasticity can be maintained or restored through conservative treatment and reconstructive surgery. To date, there is no standardized, non-invasive tool to accurately assess the elastic properties of the vagina and pelvic floor support structures. In Phase I and II of this project we have designed and clinically tested the Vaginal Tactile Imager (VTI) for visualization and assessment of mechanical properties of pelvic floor tissues [8-19]. VTI utilizes a Tactile Imaging technology we disclosed in 21 patents [20-40]. With the support of the NIH grants, Artann Laboratories received FDA approval in 2012 for the first ever tactile imaging device for prostate [41-45]. On-going Phase II VTI project requires continuation of regulatory activities and clinical validation to carry out VTI through FDA clearance to start commercial distribution of the device. Specific Aims of Phase IIB The key objectives and completion metrics of the Phase IIB are shown in Table 1. Table 1. The tasks are designed to bring the device to FDA approval. Task Goal Completion Metric Build pre-production VTI Device design and component update to comply with rd IEC 60601-1 3 ed. standards for medical devices. Four assembled devices; design documentation; tested performance. 3-D imaging software for comparative data analysis Software design and implementation for comparative analysis of multiple examinations to detect elasticity and anatomical changes in time and pre/post surgery. Software design description; documented performance. Regulatory compliance Safety, EMC/EMI testing; cleaning, high-level disinfection validation as required by new standards. Test and validation reports. Clinical validation study Validation of the device imaging and tissue characterization capability in its transformation after conservative treatment and surgery. Complete the study on 180 patients with 5 operators at 3 clinical sites. FDA submission 510(k)/De Novo submission. Full documentation package. Gantt chart showing the timeline and milestones for the project.